Cross-kingdom RNA communications between plant and fungal pathogens

SUMMARY
Fungal pathogens infect humans, animals, and plants and cause severe consequences on
global human health and crop production. Communication between hosts and pathogens is
essential for host defense and pathogen virulence, but the underlying mechanisms are not
well understood. Previous studies in my lab discovered that some non-coding regulatory
small RNAs (sRNAs) from fungal pathogens, such as Botrytis cinerea, which causes grey
mold disease on more than 1000 plant species, can be transported into host plant cells and
suppress host immunity genes, a mechanism called “Cross-Kingdom RNAi”. Recently, we
discovered that such sRNA communication is bi-directional. Plant hosts have also
developed the ability to deliver sRNAs, mainly using extracellular vesicles, to fungal cells
and induce cross-kingdom RNAi of fungal virulence-related genes. Such sRNA
communication was also observed between mammals and parasites. Although more and
more studies across diverse systems demonstrate that mobile sRNAs are key regulatory
molecules in host and pathogen interactions, the field of cross-kingdom/cross-species RNA
communication is still in its infancy. This proposal is designed to use plant Arabidopsis
and fungal pathogen Botrytis as a model system to address the outstanding questions in this
field, including, how host cells control sRNA transport upon infection, how specific classes
of small RNAs are sorted into extracellular vesicles, how fungal cells deliver sRNAs into
host cells, what are the mechanisms of RNA and vesicle uptake in the host cells and fungal
cells, and whether other classes of RNAs, such as mRNAs and long non-coding RNAs,
move between host and fungal cells, how they function in the counter party, etc.. A
combination of genetics, genomics, biochemical and molecular biology approaches will be
used. This project is expected to provide unprecedented insight into the underlying
mechanisms of cross-kingdom/cross-species RNA communications, which will ultimately
help develop innovative and eco-friendly disease control strategies and RNA-based
fungicides or antifungal drugs.

Public health relevance
RESEARCH STRATEGY 1) The parental grant abstract (R35GM136379) Fungal pathogens infect humans, animals, and plants and cause severe consequences on global human health and crop production. Communication between hosts and pathogens is essential for host defense and pathogen virulence, but the underlying mechanisms are not well understood. Previous studies in my lab discovered that some non-coding regulatory small RNAs (sRNAs) from fungal pathogens, such as Botrytis cinerea, which causes grey mold disease on more than 1000 plant species, can be transported into host plant cells and suppress host immunity genes, a mechanism called “Cross-Kingdom RNAi”. Recently, we discovered that such sRNA communication is bi-directional. Plant hosts have also developed the ability to deliver sRNAs, mainly using extracellular vesicles, to fungal cells and induce cross-kingdom RNAi of fungal virulence-related genes. Such sRNA communication was also observed between mammals and parasites. Despite more studies across diverse systems demonstrating that mobile sRNAs are key regulatory molecules in host and pathogen interactions, the field of cross-kingdom/cross-species RNA communication is still in its infancy. This proposal is designed for the use of the plant Arabidopsis and the fungal pathogen Botrytis as a model system to address the outstanding questions in this field. These questions include how host cells control sRNA transport upon infection, how specific classes of small RNAs are sorted into extracellular vesicles, how fungal cells deliver sRNAs into host cells, what are the mechanisms of RNA and vesicle uptake in the host cells and fungal cells, and whether other classes of RNAs such as mRNAs and long non-coding RNAs associate with extracellular vesicles and move between host and fungal cells as well as how they function in the counter party, etc.. A combination of genetics, genomics, biochemical and molecular biology approaches will be used. This project is expected to provide unprecedented insight into the underlying mechanisms of cross-kingdom/cross- species RNA communications, which will ultimately help develop innovative and eco- friendly disease control strategies such as RNA-based fungicides or antifungal drugs. 2) Scientific justification Request for a Blizzard NU-99828JG -86°C Ultralow Freezer The PI requests fund to purchase a Blizzard NU-99828JG -86°C Ultralow Freezer (with necessary racks) from NuAire, Inc., which will replace our 20-year-old broken -80C freezer. The old -80C freezer was unstable for the last two years, and the temperature could only go down to -50 to -40C. It was completely broken recently, which caused serious problems for the research in the lab. This instrument is essential for this project and for a molecular biology lab. It will enable us to store all the plant leaves and cultured fungal and bacterial samples, extracellular vesicles isolated from plants, fungi and bacteria, isolated small RNAs and mRNAs, all the bacterial and fungal strains etc..